Genetic and epigenetic architecture of natural telomere length variation

INTRODUCTION
This application is for a NIGMS administrative supplement for equipment for the funded R01 grant.
The parental funded grant number: 5R01GM127402-07
FAIN: R01GM127402
Principal investigator: Eugene Shakirov, PhD
Project title: Genetic and epigenetic architecture of natural telomere length variation
This application is directed to purchase the Azure Sapphire FL Phosphor Imager, the next generation of
biomolecular imager. Through the use of laser excitation and photon multiplier tube (PMT) detection, Sapphire
FL is able to scan storage phosphor screens with exceptional dynamic range and image quality. This piece of
equipment is absolutely vital for the success of the project because it has features/capabilities essential for both
aims in our research project. It will substantially speed up our progress while reducing costs in the long run.

Public health relevance
RESEARCH STRATEGY FOR THE SUPPLEMENT SCIENTIFIC JUSTIFICATION FOR THE REQUESTED EQUIPMENT We use Arabidopsis thaliana as model to discover and characterize novel genes and functional natural polymorphisms that control genotype-specific telomere lengths. Aim 1 is focused on characterizing functional natural variation in telomerase function, expression, and enzymatic activity. We also employ innovative and comprehensive genome-wide screens to identify novel trans-regulators of TERT expression and inhibitors and activators of in vivo telomerase activity. In Aim 2, we perform a series of experiments to characterize the role of previously identified candidate genes in telomere biology and length control. We also exploit several cutting-edge genomic approaches to identify additional regulators of telomere length. We have developed an effective research pipeline for candidate gene analysis that led to the identification of several novel genetic factors and pathways and we anticipate making more new discoveries. Our high-throughput assays allow us to screen up to 20 different T-DNA mutants for telomere phenotypes simultaneously. Genetic and transgenic experiments to validate the role of candidate genes in telomere length control include: 1) knock-out analysis of candidate genes for defects in telomere length; 2) transgenic rescue experiments; and 3) quantitative complementation tests. Collectively, these studies will reveal and characterize the complex genetic landscapes that underlie natural variation in telomere length set point. Both Aims 1 and 2 rely heavily on the measurement of telomere length in hundreds of various transgenic mutants and natural populations of Arabidopsis. This Southern blotting technique requires the use of radioactive P32 oligonucleotide probes to hybridize telomeric DNA in gels and subsequent scanning the signals with a Phosphor Imager. Our lab previously had a Typhoon FLA 7000 machine suitable for these assays, but unfortunately this machine is now not operational. We had a Cytiva technician come to the lab to look at it, and he had indicated that the unit cannot be repaired, as this model is so old that Cytiva is no longer manufacturing parts or providing any service. Thus, currently we do not have a Phosphor Imager, and no other lab at Marshall University has this type of equipment for imaging. We are currently using X-ray films as an alternative. However, this method has major crucial drawbacks and limitations compared to Phosphor Imaging which substantially slows down work and adds unnecessary costs. Specifically, Phosphor imaging provides a much greater linear dynamic range and higher sensitivity than X-ray film when detecting radiolabels. This allows very precise quantitation of nucleic acids which is incredibly important for our high-throughput project and not really sustainable long-term with X-ray films. With P32 half-life being only 2 weeks, without digital imaging we simply cannot analyze the necessary number of samples with X- rays before the signal disappears, especially when some assays often need to be repeated. Having access to a Phosphor Imaging capability is a major necessity, and it will be routinely used for the duration of the project. I have received a quote for Azure Sapphire FL Phosphor Imager, which is the next generation of biomolecular imagers with many benefits and extra features over the Typhoon models. It features customizable and user- changeable optical modules, laser based scanning system supporting 375 nm excitation to 900 nm emission, adjustable Z focus, 5-1000 micron resolution. Through the use of laser excitation and photon multiplier tube (PMT) detection, Sapphire FL is able to scan storage phosphor screens with exceptional dynamic range and image quality; these features are integral to the success of our study and provide unparalleled advantages for everyday use in comparison to X-rays. Sapphire FL Phosphor Imager is essential for both aims of our research project and will substantially speed up our progress. The quote for Sapphire FL Phosphor Imager covers the price of the Imager, Phosphor Standard Optical Module, dedicated Desktop Workstation with External High-Resolution Monitor for Sapphire FL, shipping & handling, device installation and training of the personnel, and AzureSpot Pro software for downstream analysis. Warranty period is for 1 year. The future recurring costs associated with the requested equipment include additional years of service contract, which will be covered through PI’s startup funds.